Investigating Interactions Between Radiation and Antibody-Drug Conjugates in Bladder Cancer

PROJECT SUMMARY
Bladder cancer is responsible for 80,000 cancer diagnoses and 20,000 deaths annually in the US. Approximately
one-fourth of bladder cancer patients will be diagnosed with muscle-invasive bladder cancer (MIBC), an
aggressive but potentially curable disease state. In the US, the most common treatment for MIBC is bladder
removal (i.e., radical cystectomy), but a bladder-sparing approach using concurrent chemoradiotherapy (CRT)
is associated with similar disease outcomes and improved quality-of-life. MIBCs harbor numerous recurrent
genetic alterations, including frequent alterations in DNA repair pathway genes, particularly nucleotide excision
repair (NER; ~15% of tumors) and homologous recombination repair (HRR; ~10% of tumors), and we and others
have shown that NER and HRR deficiency confers unique biological properties and therapeutic sensitivities. In
the past two years, two antibody-drug conjugates (ADCs) have been approved for treatment of chemotherapy-
refractory metastatic bladder cancer: enfortumab vedotin (EV) combines a nectin-4 targeting antibody with the
microtubule poison vedotin whereas sacituzumab govitecan (SG) combines a trop-2 targeting antibody with the
type I topoisomerase inhibitor govitecan. Multiple EV and SG clinical trials are now on-going in multiple bladder
cancer settings; however, the interaction of ADCs with RT in bladder cancer has not been investigated. Our
central hypothesis is that radiation upregulates nectin-4 and trop-2 expression on bladder cancer cells, and
therefore that combining EV or SG with radiation is a compelling synthetic combination strategy for MIBC
treatment. Our hypothesis is supported by preliminary data from a bladder cancer cell line demonstrating
radiation-induced increase in nectin-4 and trop-2 expression as well as synergistic cell killing when EV or SG is
combined with radiation. However, comprehensive analysis across preclinical models that represent the
molecular diversity of MIBC is currently lacking. The overall goal of the proposed work is to investigate the impact
of radiation on expression of nectin-4 and trop-2 in bladder tumors and to define the activity of EV and SG with
radiation across molecularly annotated human MIBC preclinical models. In Aim 1, we will measure radiation
dose- and time-dependent changes in nectin-4 and trop-2 at the gene and protein levels across bladder cancer
cell lines and patient-derived xenograft models. We will also test the combined effect of EV plus RT and SG plus
RT on cellular properties and tumor response in vitro and in vivo. In Aim 2, we will test the impact of NER and
HRR deficiency on sensitivity to EV- and SG-based treatments using a suite of isogenic cellular systems available
in our lab. Given the known mechanisms of vedotin and govitecan, we expect NER and HRR deficiency to
increase sensitivity to SG- but not EV-based radiation combinations. Together, we expect these studies to reveal
a novel and compelling synthetic combination strategy using ADCs with RT to effectively target bladder tumors.
We believe these studies will directly inform the design of novel clinical trials testing EV- and SG-radiation
combinations that could improve bladder-sparing treatment for MIBC.

Public health relevance
PROJECT NARRATIVE Antibody-drug conjugates (ADCs) are an attractive therapeutic strategy because they can deliver cytotoxic compounds directly to cancer cells, and two ADCs were recently approved for use in metastatic bladder cancer. Radiation is the backbone of a curative, bladder-sparing treatment approach for localized bladder cancer, but the combination of ADCs and RT has not been investigated in any bladder cancer context. We will test the hypothesis that radiation upregulates ADCs targets on bladder cancer cells and leads to a synthetic lethal combination between ADCs and radiation that could be harnessed to improve bladder-sparing treatment outcomes for bladder cancer patients.